Phenotyping and Environmental Modifiers Facility Core

Project Summary – PEMFC
Our Phenotyping and Environmental Modifier Facility Core (PEMFC) organizes Mount Sinai’s extensive
environmental epidemiology, clinical research, psychometric, data science and technical expertise as a key
Center resource. Since its inception in 2014, the PEMFC has evolved to guide selection of age-appropriate
valid and time effective, low burden approaches to measure health and disease across the lifespan with a
focus on particular critical periods or life stages (pregnancy, infancy, early childhood, adolescence, midlife,
elderly). This includes Center supported space and phenotyping equipment covering a growing list of identified
target priority areas (obesity, respiratory, allergy, sleep, renal, cardiovascular, endocrine and psychological
phenotypes). The Core also facilitates research aimed toward more fully elucidating the impacts of key
interactions between chemical toxicants and environmental modifiers, specifically many nonchemical
environmental determinants (psychological stress, social networks, lifestyle factors etc) and nutrition. A
related focus is the elucidation of mechanisms underlying health problems observed in our local
communities around Mount Sinai as well as those occurring across the country. In this next cycle, we will
promote growth in large-scale population-based environmental health research, phenomics, and
decentralized phenotyping. Our P30 Center sits within a health system comprised of 8 hospitals and over
400 practices that uses a unified Epic electronic health record (EHR). This allows us to leverage an integrated
clinical data warehouse linked with unique biobanks, providing an unprecedented foundation for integrating
our healthcare delivery and data science efforts to generate novel environmental research- especially
addressing ultraprocessed food chemicals and chronic diseases. Coupling this with our expertise in estimating
environmental exposures (ambient pollution, built environment etc.) capturing spatio-temporal variability and
incorporating timescales ranging from days to years, we can accelerate large-scale place-based health
research. We will also harness significant institutional infrastructure in digital health (apps, wearables) and
data science (machine learning) to facilitate decentralized phenotyping. The scope of responsibility for the
PEMFC includes: 1) developing, maintaining and providing access to pediatric and adult health assessments
that include self-reports, observational data, and performance-based measures; 2) tailoring protocols to
specific research needs; 3) advising psychometric analyses including the use of multiple phenotypes in a
phenomic or true multivariate analysis; and 4) providing access to unique covariates from high-resolution and
well-validated geospatial datasets. The PEMFC curates measures together with a summary of the
psychometrics as well as detailed protocol(s) for data collection, data reduction and scoring procedures, and
incorporation into analyses.